Vaccinology Training Program

This is a new application for a T32 training program that will train the next generation of leaders in vaccine
science. The Vaccinology Training Program (VTP) builds on a strong legacy of vaccine development at
Cincinnati Children’s Hospital and the University of Cincinnati that includes the oral polio vaccine pioneered
by Albert Sabin, the development of one of the world’s leading rotavirus vaccines by Drs. David Bernstein
and Richard Ward, and the more recent evaluation of multiple COVID vaccines. Cincinnati Children’s is a
longstanding site within the NIH-sponsored Vaccine and Treatment Evaluation Unit (VTEU) network, and
features unique strengths in vaccine clinical trials including controlled human infection models (CHIMs) for
evaluation of vaccines against Shigella sonnei, norovirus, cholera, and influenza; investigator-initiated trials
for novel RSV vaccines, and application of systems vaccinology tools to elucidate the cellular/molecular
pathways that lead to successful adaptive immune responses to vaccines in both young and aged
individuals. Investigators in our program lead a large U01-funded cohort study of pregnant women and their
infants studying the earliest responses to influenza infection and vaccination in order to understand the
principles of immunologic imprinting. The VTP features outstanding basic science faculty pursuing a wide
variety of projects relevant to vaccine development, including the areas of infectious disease pathogenesis,
novel immunogen design, basic aspects of immune development and regulation, computational and
functional genomics related to vaccines, and reproductive biology and immunology. The VTP will provide
training to M.D., Ph.D., and MD-PhD postdoctoral researchers that will facilitate their development into
successful independent investigators devoted to vaccine-relevant research. The program will support 4
trainees in the program per year, each appointed to 2-year terms. 22 expert mentors with strong track
records in scientific mentorship and NIH-funded research programs will serve as the VTP mentors and
faculty. Formal education in the breadth of vaccine sciences will be provided to all VTP trainees, including a
seminar course in vaccinology covering bench-to-bedside aspects of vaccinology, formal education in grant
writing, and targeted coursework relevant to the research project and focus (basic or translational) of
individual trainees. Our program is dedicated to recruitment of trainees from diverse backgrounds, races,
and ethnicities. The intended outcome is to nurture and develop VTP trainees into creative, independent
scientists who will form the vaccinology workforce of the future.

Public health relevance
This is a new application for a T32 training program in vaccinology (vaccine science). There is a great need to train future generations of MD and PhD scientists in all aspects underlying the development of vaccines. This new training program builds on a strong legacy and ongoing commitment to vaccine development and evaluation at Cincinnati Children’s Hospital, and will meet this important need.